Enhancement of Cellular DNA Flexibility

? DESCRIPTION (provided by applicant): The mechanical stiffness of DNA inﬂuences gene expression through effects on nucleosome positioning and DNA looping. However, four major gaps remain in our understanding of DNA stiffness. We do not understand what chemical features of DNA control its stiffness. We do not understand if simple polymer models are adequate to describe biologically-relevant DNA looping. We do not understand why DNA can appear softer in vivo than in vitro. Finally, we do not understand the detailed mechanisms of DNA softening by sequence-nonspeciﬁc architectural proteins. Insight into these four problems promises multiple impacts. For example, DNA-like polymers might be designed with programmed ﬂexibility, DNA looping might be controlled by sequence-targeted DNA bending proteins, and tighter gene control switches might be engineered. Our laboratories have a proven track record of collaborative experiments to probe the origin of DNA mechanical properties, and how these properties are modiﬁed by architectural proteins in cells. During the previous funding period we made important progress and now propose four aims to continue this fundamental research. Aim 1 will map architectural protein binding on tightly-looped DNA in living E. coli cells. Aim 2 will develop a novel massively parallel approach to measure DNA looping energetics and test predictions of the wormlike chain polymer model. Aim 3 will map the topology of repression loops in the DNA of living bacteria to test a hypothetical explanation for why DNA appears softer in vivo than in vitro. Finally, Aim 4 will apply single molecule and biochemical approaches to explore how sequence nonspeciﬁc high mobility group (HMGB) proteins modify the mechanical properties of DNA and chromatin in eukaryotes.

Public health relevance
PUBLIC HEALTH RELEVANCE: DNA molecules contain the information code for all living things. This information is contained in very long double-helix DNA molecules. These molecules are thread-like when considered at a distance, but are rod-like from the perspective of the proteins that must bind and read DNA. This proposal for renewed funding will allow our collaborative research group of molecular biologists, biochemists, and physicists to continue our productive projects to understand why DNA is stiff and rod-like locally, and how a special group of proteins called "architectural proteins" increase the flexibility of DNA by causing bends and kinks. .